Twist1 in Boundary Formation and Craniosynostosis

Project Summary/Abstract This is a proposal to investigate the role of tissue boundaries in cranial suture development and the pathophysiology of craniosynostosis. More broadly, this proposal focuses on how boundaries control pattern in a complex, multicomponent structure. Our recent results on the mechanism of Saethre-Chotzen syndrome, caused by heterozygous loss of function of Twist1, demonstrated that Twist1 mutant mice have a deficiency in the neural crest-mesoderm boundary at the coronal suture. The boundary normally lies between the mesoderm-derived cells of the prospective suture and the neural crest derived osteogenic cells of the prospective frontal bone. We showed that ephrin-Eph signaling, controlled by Twist1, has a role in the maintenance of this boundary: EphA4 is expressed in a layer of cells ectocranial to the prospective bone, through which osteogenic precursor cells migrate. Reduced dosage of Twist1 and EphA4 results in inappropriate targeting of migratory osteogenic precursor (MOP) cells to the coronal suture. This pathfinding defect, we proposed, is a key cause of craniosynostosis in Twist1 and EphA4 mutants. In work now under submission, we found that the Notch ligand, Jagged1, is expressed in a layer of cells in the coronal suture that demarcate the osteogenic-non-osteogenic boundary. Expression of Jagged1 is markedly reduced in such cells in Twist1 mutants. Moreover, conditional inactivation of Jagged1 in these cells results in synostosis, and to an upregulation of Notch2 and Hes1 in the suture. These results are the basis of our three-part overall hypothesis that Twist1 is at a node a regulatory hierarchy, controlling ephrin-Eph and Jagged1/Notch signaling, that Ephrin-Eph signaling functions primarily in the ectocranial mesenchyme to control MOP cell migration, and that Jagged1 functions in sutural mesoderm in the specification of border cells within the suture. To test this hypothesis, we propose first to determine whether the MOP cell targeting defect is inherent in MOP cells or is a result of a change in the ectocranial layer through which MOP cells migrate or of the sutural mesenchyme that they invade. We will approach this using conditional targeting and an array of Cre mice. Second, we will ask whether preventing the expansion of Notch2 and beta catenin expression in sutural cells mitigates the craniosynostosis phenotype, and whether forcing expression of Notch2 in sutural cells causes synostosis. Finally, we will use gene profiling to test the hypothesis that a change in the identity of cells of the coronal suture is the first event in synostosis, and that it is followed by-and exacerbated by-a defect in the targeting of osteogenic precursor cells.

Public health relevance
Project Narrative This is a proposal to study how cranial sutures form and how three genes-Twist1, EphA4 and Jagged1- control the development of specific cells within the sutures. These genes are of special interest because humans with mutations in them have birth defects that affect their skulls. By studying how these genes work, we will learn more about basic processes of skull development as well as how mutations in these genes lead to birth defects. In the long term, this work may help to devise new treatments of such birth defects. __SpecificAimsTextDelimiter__ Specific Aims This is a proposal to investigate the role of tissue boundaries in cranial suture development and the pathophysiology of craniosynostosis. More broadly, this proposal focuses on how boundaries control pattern in a complex, multicomponent structure. Our recent results on the mechanism of Saethre-Chotzen syndrome, caused by heterozygous loss of function of Twist1, draw attention, for the first time, to the significance of tissue boundaries in the development of craniosynostosis (Merrill et al., 2006). We demonstrated that Twist1 mutant mice have a deficiency in the neural crest-mesoderm boundary at the coronal suture (Merrill et al., 2006). The boundary normally lies between the mesoderm-derived cells of the prospective suture and the neural crest derived osteogenic cells of the prospective frontal bone (Merrill et al., 2006; Yoshida et al., 2008). We showed further that ephrin-Eph signaling, controlled by Twist1, has a role in the maintenance of this boundary: EphA4 is expressed in a layer of cells ectocranial to the prospective bone, through which osteogenic precursor cells migrate (Roybal et al., submitted; Ting et al., 2009). Reduced dosage of Twist1 and EphA4 results in inappropriate targeting of migratory osteogenic precursor (MOP) cells to the coronal suture. This pathfinding defect, we proposed, is a key cause of craniosynostosis in Twist1 and EphA4 mutants (Ting et al., 2009). We noted also that the synostosis phenotype caused by loss of EphA4 function is less severe than that of Twist1+/- mutants (Ting et al., 2009), leading us to postulate that there are additional genes downstream of Twist1 functioning in the maintenance of the osteogenic-non-osteogenic boundary and in the pathophysiology of craniosynostosis. In a manuscript under submission, we provide evidence that the Notch ligand, Jagged1 is such a gene (Yen and Maxson, submitted). In humans, heterozygous loss of function of the Notch ligand, JAGGED1, results in Alagille syndrome, a multi-organ disorder that includes coronal synostosis as a feature (Alagille et al., 1987; Emerick et al., 1999; Kamath et al., 2004; Krantz et al., 1998; Oda et al., 1997). Jagged1 is expressed in a layer of cells in the coronal suture that demarcate the osteogenic-non-osteogenic boundary. The production of "border cells" between two compartments is a major function of boundaries (Blair, 2003; Irvine and Rauskolb, 2001). These cells are sources of morphogens that influence the fate of cells flanking the boundary in developmental systems. Jagged1-expressing sutural cells, we propose, may serve as border cells. Expression of Jagged1 is markedly reduced in Twist1 mutants (Preliminary Results). Moreover, conditional inactivation of Jagged1 in sutural cells results in synostosis, and, surprisingly, to an upregulation of Notch2 and Hes1 in the suture. Thus synostosis is associated with enhanced Notch signaling. These results are the basis of our three-part overall hypothesis: (i) that Twist1 is at a node a regulatory hierarchy, controlling ephrin-Eph and Jagged1/Notch signaling, (ii) that Ephrin-Eph signaling functions primarily in the ectocranial mesenchyme to control MOP cell migration, and (iii) that Jagged1 functions in sutural mesoderm in the specification of border cells within the suture. These are our specific aims: 1. To investigate the cellular and molecular mechanisms by which Twist1 controls MOP cell targeting. We will ask whether the MOP cell targeting defect is inherent in MOP cells or is a result of a change in the ectocranial layer through which MOP cells migrate or of the sutural mesenchyme that they invade. We will approach this using conditional targeting and an array of Cre mice that will enable us to tease out the activies of Twist1 in these several tissues. In addition, we will further define the ability of calvarial cis-regulatory elements at the ephrinA4 locus to drive cell type-specific expression, both to develop new Cre reagents specific for the ectocranial layer, and in the long term to understand how Twist1 regulates ephrinA4 expression and thus MOP cell migration. Finally we will seek to develop a slice culture model of coronal suture development. 2. To test the function of the Notch pathway in the specification of sutural cells and the pathophysiology of craniosynostosis. We will ask whether genetic maneuvers that reduce the expansion of Notch2 and beta catenin expression in sutural cells mitigate the craniosynostosis phenotype. In a complementary gain of function approach, we will force expression of Notch2 in sutural cells by means of a transgenic mouse line in which the Notch2 intracellular domain (ICD) is expressed in response to the cell type- specific expression of Cre recombinase. We expect that this will mimic loss of Jagged1 function and will result in synostosis. 3. To evaluate the relative contributions to the craniosynostosis phenotype of a change in the identity of sutural cells and the mis-targeting of migratory osteogenic cells. We will use gene profiling to test the hypothesis that a change in the identity of cells of the coronal suture is the first event in synostosis, and that it is followed by-and exacerbated by-a defect in the targeting of osteogenic precursor cells. We will use an Affymetrix chip approach, and in the longer term, RNA seq to profile sutural cells in different mutant backgrounds-Mesp1-Cre; Jagged1cko/cko, and EphA4-/-. An additional goal is to evaluate the hypothesis that sutural cells function as "border cells," exhibiting signaling activity that organizes the development of osteogenic and non-osteogenic territories at the suture.